Leveraging reactive metabolite generation in brain tumors

PROJECT SUMMARY
Gliomas rank among the deadliest forms of cancer. Mutations in isocitrate dehydrogenase 1 or 2 (IDHm) define
a molecular subtype of adult gliomas that typically afflict younger patients. Standard of care includes surgical
resection, radiation, and chemotherapy. However, this regimen only delays progression and patients inevitably
face tumor recurrence and premature death. There is a need for novel therapies for IDHm glioma patients.
IDHm produces the oncometabolite D-2-hydroxyglutarate, which disrupts redox homeostasis by depleting
glutathione (GSH). GSH is essential for the detoxification of methylglyoxal (MGO), a reactive metabolite that is
spontaneously produced during glycolysis. Unless detoxified, MGO induces apoptosis by irreversibly damaging
proteins and DNA. Tumors adapt to MGO production by upregulating glyoxalase 1 (GLO1), which uses GSH to
eliminate MGO. Our studies with patient-derived IDHm glioma models and patient biopsies indicate that D-2HG
acts via the NRF2 transcription factor to upregulate GLO1 expression. Inhibiting GLO1 using the potent brain
penetrant GLO1 inhibitor S-p-bromobenzylglutathione cyclopentyl diester (BBG) abrogates MGO detoxification
and arrests tumor growth in mice bearing orthotopic patient-derived IDHm gliomas. Importantly, radiation
depletes GSH, and combined treatment with BBG and radiation causes massive MGO accumulation,
macromolecular glycation, and tumor regression in vivo. Based on these results, we will test the hypothesis that
targeting GLO1 in combination with radiation is lethal for IDHm gliomas. In Aim 1, we will determine whether the
combination of BBG with radiation is an actionable therapeutic strategy in patient-derived IDHm glioma models.
In Aim 2, we will delineate the molecular mechanisms governing reactive metabolite generation in IDHm gliomas.
Deuterium magnetic resonance spectroscopy is a novel, clinically translatable method of visualizing the
metabolism of 2H-labeled substrates in vivo. Our studies indicate that MGO glycates the glycolytic enzyme
phosphoglycerate kinase 1, thereby reducing lactate production from [6,6-2H]-glucose in IDHm tumor-bearing
mice. Therefore, in Aim 3, we will determine whether [6,6-2H]-glucose provides an early readout of response to
combined BBG and radiation in mice bearing IDHm gliomas in vivo. Our proposal is innovative because we will,
for the first time, mechanistically validate reactive metabolite generation as a druggable vulnerability in IDHm
gliomas. This project is significant because our studies will set the stage for clinical translation of the combination
of BBG and radiation to IDHm glioma patients. Concomitantly, [6,6-2H]-glucose will enable early assessment of
efficacy in clinical trials. In essence, by simultaneously targeting metabolism and imaging treatment response,
we will deliver precision medicine that enhances outcomes and quality of life for IDHm glioma patients.

Public health relevance
PROJECT NARRATIVE There are no curative therapies for mutant isocitrate dehydrogenase (IDHm) glioma patients. Our studies indicate that targeting the metabolic enzyme glyoxalase 1 (GLO1) is lethal in combination with radiation for IDHm gliomas, and that deuterium metabolic imaging provides an early readout of response to therapy. We anticipate that clinical translation of our studies will enable precision medicine and imaging for IDHm glioma patients.